Mechanisms and Modulation of Opsin 3 Mediated Airway Smooth Muscle Relaxation

Project Summary/ Abstract
Light-mediated relaxation of smooth muscle has been recently demonstrated. Non-visual opsins
expressed on smooth muscle have been implicated as the key mediator of relaxation via light within the visible
spectrum. However the mechanism of relaxation has yet to be fully understood. Our group has demonstrated
that this phenomenon is also present in airway smooth muscle with light-mediated relaxation modulated by opsin
receptors coupled to G protein signaling pathways. In preliminary studies, we demonstrate that airway smooth
muscle photorelaxation is wavelength- and intensity-dependent and that light induces an interaction between the
opsin 3 receptor and Gαs demonstrated by co-immunoprecipitation. This was associated with an increase in
intracellular cyclic AMP, a known key second messenger of airway smooth muscle relaxation. We propose to
identify the opsin receptors subtype(s), the G protein(s) and the cellular signaling pathways (e.g. cAMP, cGMP,
and cytoskeletal regulatory proteins (RhoA, CPI-17 and myosin light chain-20) that modulate airway smooth
muscle photorelaxation. We will also explore the mechanism of activation by modulating the light wavelength
sensitivity of airway smooth muscle. Normally opsin receptors bind 11-cis-retinal (a chromophore and co-
activator with photons of light) to form a Schiff base. The 11-cis-retinal allows for photoisomerization that changes
the conformation of the opsin receptor, which induces downstream cellular signaling. Derivatives of retinal have
been shown to shift the sensitivity of opsins to longer wavelengths. In our proposal we demonstrate that the use
of 11-cis 2,3 didehydroretinal shifts airway smooth muscle sensitivity to longer wavelengths. We propose to
evaluate additional retinal derivatives in cellular, in vivo and ex vivo models to identify chromophores that can
shift the wavelength sensitivity of endogenous opsins to respond to longer wavelengths of light that may
penetrate the body. In the eye, the sensitivity to different wavelengths of light is not only a function of the specific
ligand but also a function of the subtype of opsin receptor expressed. Transfection of variants of OPN1 will allow
evaluation of specific ligands at varying wavelengths of light in airway smooth muscle that activate cellular
signaling congruent with relaxation. We will explore the direct activation of opsin receptors by carotene
metabolites in the absence of light. We will demonstrate that the endogenous metabolite of carotenes, β-ionone,
is a phytochemical that can directly activate opsin 3 in the absence of light. We will show that the same pro-
relaxant cellular signaling occurs in airway smooth muscle when the opsin 3 receptor is directly activated by -
ionine as compared to activation by chromophores/light. These proposed studies will allow for a better
understanding of the activation and signaling of a previously uncharacterized receptor expressed in airway
smooth muscle that modulates pro-relaxant signaling pathways.

Public health relevance
Project Narrative Light-mediated relaxation of airway smooth muscle is a novel discovery by our laboratory but the cellular signaling mechanisms of opsin receptor activation have yet to be determined. We will identify the receptor signaling pathways by using synthetic retinal derivatives and the transfection of opsin receptors to change wavelength sensitivity of airway smooth muscle. We will also explore the mechanism of endogenous activation of opsin receptors with a naturally occurring direct agonist, β-ionone, that has the ability to activate opsin receptors in the absence of light.